Virginia Commonwealth University IRACDA

The future of biomedical research depends on a diverse pool of well-trained scientists who are equipped to
investigate the priority health issues of the 21st century. In addition, it is necessary to nurture a cadre of
enthusiastic, ambitious, inclusive and creative educators who can inspire their students to pursue careers in
research. Because postdoctoral training typically focuses on research, future educators face the challenge of
developing both the teaching skills and the research portfolio necessary to be competitive for faculty positions.
As an urban research-intensive institution with a medical school, Virginia Commonwealth University (VCU) is
uniquely positioned to provide this training. The VCU IRACDA program has collaborated with Virginia State
University (VSU) since 2010, and is designed to address this challenge with two major goals. The first is to
prepare postdoctoral fellows for faculty positions through career development in both cutting edge research and
pedagogy. VCU IRACDA scholars perform research under the guidance of experienced mentors, and participate
in hands-on mentored teaching at our partner historically black university VSU. The second goal of VCU IRACDA
is to enhance collaborations between VCU and VSU, by expanding the VSU curriculum and promoting research
opportunities for students and faculty. These goals will be accomplished through the following specific aims: (1)
Annually identify at least 6 highly qualified applicants and recruit 2 outstanding postdoctoral scholars to the 3-
year VCU IRACDA program (steady state 6 scholars); (2) Provide VCU IRACDA postdoctoral fellows with
integrated and intensive career development in research and teaching; (3) Enhance the curricular offerings and
research environment at VSU through course delivery with a strong foundation in current research trends and
methodologies; and (4) Continue our rigorous evaluation and tracking system for longitudinal follow-up of VCU
IRACDA program impacts on scholars and on VSU students and faculty members.

Public health relevance
There is a pressing need to make the biomedical research enterprise in the US more inclusive. With our dedicated team of teaching and research mentors, comprehensive and rigorous career development regimen, and talented pool of postdoctoral scholars, VCU IRACDA is making significant contributions to this effort.